Training Program in Neurobiology of Information Storage

PROJECT SUMMARY
This application seeks to renew the
Neurobiology of Information Storage Training Program (NISTP), which is
devoted to
preparing exceptional
predoctoral
students for research-intensive careers in the science of learning
and memory. Active since 2003, the program is focused on training in fundamental mechanisms of information
storage in animals and humans, acting as a central organizer for research in this area at Northwestern. With
the recent shift in mental health research toward dimensional, systems-based frameworks there is
unprecedented need for training of the kind offered through this program, which provides training at multiple
levels of analyses for understanding mechanisms of learning and memory and their relevance to mental health.
The NISTP is based in the Northwestern University Interdepartmental Neuroscience (NUIN) program,
emerging from a multidisciplinary group of 29 interactive investigators who have successfully engaged in
collaborative research on molecular/genetic, cellular/circuit, and systems/behavioral determinants of
information storage. NISTP preceptors have strong track records in predoctoral training and well-funded
research programs, and can impart both basic and clinical perspectives to a group of outstanding developing
scientists. Training components of the NISTP will include: 1) an advanced course in the latest research in
information storage neurobiology, taught by NISTP preceptors; 2) two trainee-hosted lecture series featuring
leading investigators in the field of information storage; 3) mock study sections for trainees preparing NRSA
applications; and 4) quarterly NISTP meetings including a) “research in progress” trainee talks, b) “bench to
bedside” translational discussions, c) “computational modeling and memory” interactive discussions, and d) the
annual NISTP retreat. NISTP also serves to educate students in the ethics of science and to recruit students
from underrepresented groups to study learning and memory. Continuous evaluation of the program will be
accomplished using qualitative mechanisms, such as evaluations by trainees, and quantitative measures, such
as tracking the research productivity, funding, and career trajectories of former trainees. An internal Steering
Committee and an External Advisory Committee will conduct additional assessment processes.Trainees are
drawn primarily from a pool of NUIN students who have completed most of the required coursework and have
We r equest continued support for five trainee slots, which
will be supplemented with one institutionally funded “affiliate” slot . With the value added by the NISTP, we are
confident that NISTP trainees will emerge from their graduate training poised to advance research in
fundamental biological mechanisms of learning and memory and well positioned to develop novel translational
applications.
made significant progress in their thesis research.

Public health relevance
Project Narrative Many psychiatric disorders, including stress-related, affective, autism spectrum, and psychotic disorders, are associated with abnormal learning and memory. This proposal is a request for renewed funding of the predoctoral Neurobiology of Information Storage Training Program to prepare the next generation of scientists to understand, at the most fundamental level, the process of learning and memory and its relevance for mental health.